Therapeutic Potential of ALK1 Activating Drugs in HHT Models

PROJECT SUMMARY/ABSTRACT (DESCRIPTION)
Hereditary hemorrhagic telangiectasia (HHT) is a highly debilitating and potentially life-threatening systemic
vascular dysplasia characterized by arteriovenous malformation (AVM) development in several tissues. HHT is
caused by loss-of-function mutations in ALK1, ENG, and Smad4, three signal transducers of the TGF-β family
ligands, BMP9 and BMP10. ALK1, an endothelial BMP type I receptor, interacts with a BMP type II receptor and
the co-receptor ENG to activate Smad1/5/8, mobilize Smad4, and control specific gene expression programs
involved in vascular maintenance. In collaboration with Diagonal Therapeutics (DGL), we obtained a clustering
bispecific antibody (BsAb) that binds the extracellular domains of ALK1 and the BMP type II receptor, BMPRII.
We found that DGL's BsAb (DGL-BsAb) increased ALK1 and BMPRII levels at the cell surface and produced a
sustained Smad1/5/8 activating response in endothelial cells (ECs) in vitro. Strikingly, DGL-BsAb prevented and
reversed retinal AVMs in mice treated with BMP9/10 blocking antibodies (BMP9/10ib mice), a model of HHT. In
addition, DGL-BsAb activated Smad1/5/8 signaling in blood outgrowth ECs isolated from HHT patients carrying
ALK1 mutations. The overall goal of this application is to determine whether ALK1-BMPRII receptor activation
rescues Smad1/5/8 signaling and treats the different HHT pathologies in pertinent mouse models, as well as to
study the mechanisms of ALK1-BMPRII receptor activation upon binding to DGL-BsAb. In Aim 1, we will assess
the anti-AVM properties of ALK1-BMPRII receptor activation in the retinal vasculature of BMP9/10ib and ENG
inducible EC-specific knockout (iECKO) mice. The endothelial and mural cell defects, hypervascularization,
vessel dilation, and arteriovenous specification disruption accompanying AVM pathology in these two HHT
mouse models will also be investigated. Aim 2 will determine the efficacy of ALK1-BMPRII receptor activation in
treating systemic vascular defects in newborn and adult HHT mouse models. We will assess liver, lung, and
brain vascular defects, bleeding, and anemia following DGL-BsAb treatment in newborn BMP9/10ib and ENG
iECKO mice and adult HHT mutant ALK1 knock-in mice. Transcriptomic analyses will be performed in liver ECs
to identify the anti-AVM gene expression signatures of DGL-BsAb treatment in HHT mice. Aim 3 will identify the
mechanisms and downstream signaling pathways of ALK1-BMPRII receptor activation by DGL-BsAb. We will
first confirm the proper target engagement by DGL-BsAb by determining whether Alk1 and Bmpr2 knockdown
precludes DGL-BsAb-mediated Smad1/5/8 signaling activation in ECs and AVM blockade in HHT mice. We will
then analyze whether DGL-BsAb controls ALK1-BMPRII interaction, stabilization, and endocytosis. Lastly, we
will use RNA-seq in HUVECs to compare the gene expression signatures of DGL-BsAb and BMP9 treatments
to identify the specific signaling pathways associated with ALK1-BMPRII activation.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (NARRATIVE ATTACHMENT) Hereditary hemorrhagic telangiectasia (HHT) is a highly debilitating genetic bleeding disorder for which no effective cure is currently available. In this application, we propose determining whether a newly identified antibody targeting the ALK1 receptor could have disease-modifying properties in HHT experimental models. This strategy could pave the way for new clinical investigations in HHT.